CLINICAL PHARMACOLOGY

The clinical pharmacology of antineoplastic agents used in the treatment of pediatric malignancies is studied with emphasis on the role of pharmacologic monitoring and on both pre-clinical and clinical pharmacologic studies of Phase I agents. The clinical pharmacology of orally administered antileukemic agents has been evaluated and the limited bioavailability and variable drug levels of 6-MP achieved following oral administration has been documented. Studies are underway to determine the extent to which this phenomenon is the cause of treatment failure. Additional efforts to optimize 6-MP administration have been based on in vitro studies which have demonstrated a need for prolonged exposure to cytocidal concentrations of drug to maximize leukemic cell kill. Clinical Phase II protocols evaluating prolonged intravenous 6-MP infusions for acute leukemia, brain tumors and solid tumors are underway. Preclinical and clinical pharmacokinetic studies of the new agent, Trimetrexate, have been pursued and a pediatric Phase I study completed. Phase I studies of 2 new agents, Spiromustine and Fludarabine are in progress as is a Phase II study of the Methotrexate-5 FU combination. A major effort of this project is to study experimental approaches to the treatment of both meningeal and non-meningeal CNS malignancy. A unique sub-human primate model which allows sterile, repetitive access to cerebrospinal fluid, is utilized to study the CNS pharmacokinetics of various intrathecally and intravenously administered chemotherapeutic agents; to evaluate the neurotoxicities attendant upon various CNS treatments; and to evaluate and screen in a pre-clinical setting newer CNS treatment modalities and drug schedules. Information gained from the studies with this model is then applied to the design of clinical treatment protocols. A clinical study of intrathecal AZQ is in progress. Pre-clinical studies evaluating intra-CSF drug administration via indwelling drug delivery devices is under way.